Administrative Supplement: A planning project to pilot test and optimize dietary approaches to slow aging and design a long-term trial

PROJECT SUMMARY
Calorie restriction (CR) is defined as eating a nutritionally adequate diet that is below energy requirements. CR
has been studied for almost 100 years and has been found to extend the lifespan and healthspan of numerous
species. Further, when tested in young and middle-aged humans, modest CR improves healthspan and slows
biological aging. However, adherence to CR has been found to decrease over time, calling into question the
long-term viability of this approach. A possible alternative to CR that may have better adherence and
acceptability is time-restricted eating (TRE), which involves eating one's food in an 8 to 10-hour period of the
day. TRE extends the lifespan of rodents, and based on recent human trials, TRE improved disease risk
factors and biomarkers of aging. Further, many benefits of TRE were achieved even when weight loss did not
occur. During the parent award (U01 AG073204), we are conducting a planning project to determine the
feasibility and preliminary efficacy of CR and TRE, which are being delivered via traditional in-person visits and
remotely via mobile health technologies. Data from the planning project will help select the CR intervention and
identify if and what type of TRE intervention will be tested in a future 5-year trial. Our project will also provide
effect size estimates for aging outcomes to adequately power the 5-year trial. The proposed supplement will
support close out funds to complete participants' follow-up appointments, data collection and to ensure safety
monitoring on the remaining participants. The supplemental funds are necessary due to unforeseen costs
incurred by the study, such as increased participant stipends and marketing costs to enrol eligible participants.

Public health relevance
PROJECT NARRATIVE The close out funds will support completion of DiAL Health (U01 AG073204), a planning project to pilot test and optimize dietary approaches to slow aging and design a long-term trial. DiAL Health is a multi-site study, with sites at Pennington Biomedical in Baton Rouge, Louisiana and the University of Alabama Birmingham. The close out funds will be used to finish the study, including completion of participant follow-up appointments, ensuring their safety and completion of data collection on the remaining participants.